Effects of THC on Alcohol Consumption and Neural Correlates of Reward

PROJECT SUMMARY / ABSTRACT
Cannabis is commonly co-used by individuals who drink alcohol, such that their intoxicating effects overlap
(known as `simultaneous use'). Simultaneous use is known to be associated with experiencing increased
negative consequences, however, evidence is conflicting regarding whether cannabis acutely increases or
decreases alcohol consumption. The neural mechanism(s) underlying simultaneous use are also not well
understood. Existing research suggests that overlapping neural mechanisms underlie the effects of alcohol and
THC (Δ-9-tetrahydrocannabinol, the primary psychoactive substance in cannabis), and this circuitry may affect
motivation for alcohol misuse and simultaneous use. Specifically, cannabinoid receptors (i.e., CB1, to which
THC binds as a partial agonist) are distributed throughout the mesolimbic brain regions that underlie alcohol
reward. Activation of CB1 is thought to influence neural circuitry underlying reward signaling, such that reward
signaling may be amplified by THC, however it is unclear whether THC sates or primes reward-responses to
alcohol. An important limitation of prior work is that most studies have used THC doses that are significantly
below the level used in the real world. Legal-market cannabis products containing high levels of THC are
increasingly popular and available, but their effects neural reward processing and acute alcohol self-
administration have not been studied in the laboratory. We propose to test the effects of a 20mg oral dose of
THC (i.e., a dronabinol capsule) vs 0 mg THC (placebo capsule) on reward processing during alcohol and
cannabis cue-reactivity tasks in 25 adults who drink alcohol and use cannabis. Participants will complete a
baseline session and 2 experimental laboratory sessions in this double-blind pharmaco-imaging study with a
crossover design. At one experimental session, participants will consume THC before undergoing a brain scan
and participating in an intravenous (IV) alcohol self-administration session. At the other experimental session,
they will undergo the exact same study procedures after consuming the placebo capsule. Session order will be
counterbalanced. We will also examine if neural responses to THC are associated with real-world co-use
patterns as assessed by two weeks of daily-diary data collection. The pharmacokinetics of oral THC provide a
long time period of elevated blood THC levels, allowing us to perform an MRI scan and IV-alcohol session
while THC remains at peak blood levels. We hypothesize that individuals who experience stronger neural
reward signaling or reduction in aversive signaling following 20mg dronabinol vs placebo will self-administer
more IV alcohol and report more frequent simultaneous alcohol and cannabis use during the daily diary period.
Aims include examining the effect of oral THC on neural response to reward (i.e., alcohol and cannabis cues),
examining the effect of oral THC on alcohol self-administration, and examining the relationship between neural
reward responses and alcohol consumption.

Public health relevance
PROJECT NARRATIVE Alcohol and cannabis are often used together such that their effects overlap (known as `simultaneous use') but evidence is conflicting regarding whether simultaneous use promotes increased or decreased alcohol intake, and little is known about the neural mechanisms that underlie simultaneous use. Real-world doses of THC have not been well-studied in the laboratory, and it is unclear how high doses of THC may impact alcohol consumption patterns. The proposed study will explore the effects of oral THC (20mg dronabinol) vs. placebo on neural reward, intravenous alcohol self-administration and naturalistic co-use patterns, and findings could impact public health and inform individual choices regarding co-use of cannabis and alcohol.